Structure and function of the monotopic phosphoglycosyl transferase superfamily: Initiators of biosynthesis of complex bacterial glycoconjugates

Complex glycoconjugates play a pivotal role in bacterial survival, colonization and virulence and contribute
to the interactions between symbiotic and pathogenic bacteria and their human hosts. An important
mechanism for the assembly of these structures is initiated on the cytoplasmic face of cell membranes,
catalyzed by polyprenol phosphate (PrenP) phosphoglycosyl transferases (PGTs). PGTs transfer a C1’-
phosphosugar from a soluble nucleoside diphosphate (NDP) activated donor to a PrenP acceptor, yielding
a membrane-bound polyprenol diphosphosugar. Our studies focus on a PGT superfamily with a monotopic
membrane topology (monoPGTs) for which, until our recent studies, there has been only limited structural
and mechanistic information. These enzymes differ from the well-known polytopic PGTs (polyPGTs), which
bear many membrane-spanning sequences. Biochemical studies and the structure of Campylobacter
concisus PglC, show that the monoPGTs include a reentrant membrane helix (RMH) that penetrates only
one leaflet of the bilayer, then re-emerges. This program will pursue synergistic biochemical, bioinformatic,
structural and chemical biology studies of the monoPGTs. In Aim 1 structures will be determined via X-ray
crystallography with detergent-solubilized protein and, in a membrane environment, by solubilization into
lipid nanoparticles and crystallization in the lipidic cubic phase. Cryo-EM in lipid nanoparticles will also be
pursued for members of optimal size. Together with substrate and inhibitor liganded structures and activity
analysis, we will elucidate the specificity determinants of newly-identified monoPGTs and provide
information on their function in the glycoconjugate biosynthetic pathways of various pathogens. In Aim 2,
the model that binding of the UDP-sugar substrate triggers the movement of a soluble loop to complete
substrate-binding determinants and close the active site for catalysis, will be tested using cross-linking and
fluorescence-based approaches in detergent-solubilized and model membrane environments. To provide
complementary insight into the binding of the membrane-resident PrenP substrate, the RMH sequences
will be analyzed via informatics. This information will be used to develop hidden Markov models to identify
RMH segments within the monotopic PGT superfamily and used to predict RMHs in unrelated proteins
families across the proteome. Aim 3 will develop nucleoside analogs that will serve as inhibitors and
activity-based protein profiling probes of the monotopic PGT superfamily. This analysis will define the
contribution of ligand moieties to binding and identify new PGTs and their significance in bacterial
metabolism and host infection. Ultimately, the identified proteins can act as targets for the development of
new antibacterial and antivirulence agents. Overall, this in-depth study of the structures and binding
landscape of the monoPGT superfamily and design of biological probes will establish the fundamental
knowledge and tools needed for validating and intervening in the action of potential therapeutic targets.

Public health relevance
Narrative The biosynthesis of complex sugars is fundamental to bacterial survival and to the interactions between bacterial pathogens and symbionts and their human hosts. The proposed studies will uncover how a superfamily of enzymes act at bacterial membranes to carry out an initial, critical step in complex sugar assembly. The understanding of how the molecular structure and dynamics lead to function will allow the design of ligands and probes to identify and ultimately yield therapeutic control over pathways that contribute to bacterial survival and virulence.